Marriage Education and Risk Reduction for Army Families

DESCRIPTION (provided by applicant): Consistent with NICHD's mission to support research on relationship dynamics, divorce, and interventions to promote strong and healthy families, we seek a continuation of a community level, controlled, longitudinal and randomized dissemination trial of the effectiveness of an empirically-based relationship education program for Army couples delivered by Army chaplains. The intervention is an adaptation of the Prevention and Relationship Enhancement Program (PREP) for Army couples, designed to target risk and protective factors for marital distress which are associated with problems in individual and family functioning. Our current funding period allows us to assess the effects of the intervention for up to 3.5 years post intervention in a sample of 662 couples (343 PREP, 319 control). We seek a continuation of this project in order to test impacts and marital processes over a longer time frame (up to 8.5 years post intervention). The longer time frame is important for the prospective evaluation of intervention effects for relationship quality and individual adjustment over time, and gain greater power to detect intervention effects for outcomes that accrue over time, such as divorce and infidelity. Our specific aims for the renewal are: 1. To assess the long-term effects of an empirically-based relationship education program on relationship quality, relationship stability, and individual mental health. 2. Assess the long-term effects of relationship education on outcomes of specific relevance to the military context, including PTSD symptoms and infidelity. 3. To build knowledge to inform and revise future prevention efforts. We plan to achieve these aims using survey assessments with our existing sample over an additional five year period, building on a strong initial phase which addresses many key limitations in the literature on relationship education. The sample is large, relatively diverse, and comprised of married couples (many with children) rather than premarital couples (the focus of most prior research). The proposed study will be the strongest of its kind. Our measurement evaluates a wide range of important, understudied, relationship constructs. The stressors experienced by this sample related to factors such as deployment should provide more variance on key outcomes than typically seen in relationship education studies. The proposed renewal is significant in the ways that it can advance scientific knowledge on the long-term effects of relationship education and processes of marriage and divorce over time, with the potential to inform interventions for preventing or treating relationship distress.

Public health relevance
Marital functioning is important for the physical, mental, and economic health of families. Therefore, this project has direct public health implications and import.